Chemistry Discipline B Track 4

Chemistry B Track 4 Project Summary: The Michigan Department of Agriculture and Rural Development, Food, Fuel, and Disease section plans to develop the capability to analyze human and/or animal food for multiple allergens. The section has contacted a vendor for the procurement of the MagPix System with XPonent 4.2, a programmable shaker, u- bottom block, flat bottom assay plate, and cover blocks. The section is looking into the necessary training for the analyst(s) that will be performing the setup, and process. Work to secure training for personnel on the xMAP Food Allergen Detection Assay (xMAP FADA). The section intends to perform the necessary validation of the method. Prior to service samples being run the analysis shall demonstrate competency through a proficiency test offered by a suitable proficiency testing program.

Public health relevance
Chemistry B Track 4 Project Narrative: Allergens are a current and emerging hazard within the world food chain. Proper identification of label ingredients is crucial for the health and safety of the consumer and the safety of those who use those ingredients further down the supply chain. The Michigan Department of Agriculture and Rural Development Food, Fuel, and Disease Section intends to use the funding from this opportunity to develop a testing program for allergens in human and animal food products.